Biobanking and Phenotyping Core

Project Summary/Abstract—Biobank & Phenotyping Core (BPC)
Translational research will continue to play a central role in the 21st century research and clinical practice, but
substantial barriers exist to accessing clinical data, biospecimens, and cutting-edge genomic and proteomic
technologies and analytics.
The Washington University Rheumatic Diseases Research Resource-based Center (WU-RDRRC) Biobank and
Phenotyping Core (BPC) eases the high hurdle of executing rigorous translational research by streamlining and
accelerating the process from clinical data and biospecimen access and collection to full analysis. The goals of
the BPC are to 1) improve access archived clinical data and biospecimens and assist with the prospective
collection of the same, 2) access cutting-edge technologies including next-generation sequencing platforms,
mass cytometry including imaging mass cytometry, and spatial transcriptomics, and 3) provide sophisticated
informatics and biostatistical support and education for the integration of registry data along with molecular data
generated in #2. These services also interface with other WU-RDRRC Cores such as the Genome Engineering
Core and the Cellular Imaging Core to provide preclinical functional testing. We accomplish the goals of the WU-
RDRRC BPC through the following three Specific Aims:
Aim 1. Facilitate the collection of rigorously phenotyped clinical data and high-quality biospecimens using the
BPC-Biobank. The BPC-Biobank provides WU-RDRRC members a unified mechanism to access archived
samples and simplify the prospective collection of data and samples for investigators, preventing duplication of
complicated logistics and providing substantial cost savings.
Aim 2. Support state-of-the-art proteomic, genomic, and transcriptomic methods to interrogate human
biospecimens and murine samples: The BPC Biospecimen Analytics Core (BAC). The BPC-BAC integrates
cutting-edge technologies to extract molecular features from biologic samples in a streamlined pipeline that
dramatically reduced the learning and access to execute impactful translational research. Both proteomic and
genomic features (including spatial transcriptomics) are obtained using highly streamlined workflows
individualized to each investigator’s needs at discounted rates for WU-RDRRC members.
Aim 3. Provide integrated bioinformatics and analytics support for complex datasets: the Integrative Informatics
Core (IIC). The BPC-IIC maximizes research potential by directly and simply addressing the “last mile” problem
in translational research. By easing access to high-level complex analytic pipelines, the IIC provides “one-stop
shopping” for WU-RDRRC members to leverage the wide array of advanced analytic pipelines and expertise
with complex datasets by providing informatics and biostatistical services and education that enable the
integration of individual-level clinical, demographic, SDOH, and PRO data collected in Aim 1 with proteomic and
NGS molecular datasets in Aim 2.